Project 3 - Walter_Vandenborne

Abstract: Project 3
Project 3 serves as the clinical research project for this Center application, complementing
preclinical therapeutic development in Projects 1 & 2. Building on our expertise in noninvasive
magnetic resonance (MR) biomarker development, we determine the contemporary natural
history of gene therapy treated patients with Duchenne muscular dystrophy (DMD) and in a rare
form of limb girdle muscular dystrophy, sarcoglycanopathy (LGMDR3/R5).
Our central hypothesis is that quantitative MR can be used as a biomarker for early skeletal and
cardiac muscle disease progression and inflammation, to monitor the impact of AAV based
therapies. Micro-dystrophin (µDys) gene therapy has emerged as a promising treatment strategy
with recent FDA approval changing the landscape in DMD. However, the truncated nature of the
µDys protein and the need for high concentrations of current AAVs may limit therapeutic efficacy
and present some unique challenges. Therefore, in Aim 1 we will determine the disease trajectory
of individuals with DMD treated with a clinically approved µDys-AAV and evaluate the impact on
cardiac muscle. In Aim 2, we will extend our biomarker work to LGMDR3/R5, an underserved
patient population in therapeutic development. We will use a combination of MR biomarkers and
serum/urine biomarkers to characterize the natural history of disease progression and help
identify therapeutic targets and novel biomarkers for future AAV clinical trials in this population.
Finally, in Aim 3, we will validate MR parametric mapping of the myocardium to detect cardiac
remodeling, inflammation, and any reaction to a large dose of AAV in a large rodent model of
DMD, with the goal of implementing this approach in young children undergoing gene therapy.